Medical Scientist Training Program at Tufts University

The mission of the Tufts MD-PhD program is to foster the development of talented trainees into successful, resilient, and innovative physician-scientist leaders who will drive solutions to existing, emergent, and future critical health care challenges. Using the best evidence-based teaching practices, our objectives are to promote knowledge and skills for conducting and leading rigorous and reproducible research, the achievement of excellence in clinical medicine, and the development of competencies that promote the resilience needed to identify, adapt, and sustain efforts to meet evolving unmet healthcare needs in our society. The rationale for this approach is that ~24% of MSTP trainees nationwide pursue private practice, highlighting the need for training approaches that optimize training outcomes and continued participation in research. To enhance trainee success and propel them to leadership in academic medicine, we provide trainees with new and evolving tools for recognizing and coping with the complex stressors of modern academic medicine. These include novel curricula in: Wellness and Resilience and Physician Leadership; enhanced, evidence-based mentor training; new computational biology courses; and a clinical and translational training option for those who wish to focus on patient-oriented research. We continue to provide a highly integrated approach to training with flexibility built in to accommodate dual degree students. We offer a clinical clerkship prior to entry into graduate training, and an abbreviated Family Medicine clerkship during graduate school which allows students to stay firmly connected to clinical medicine providing flexibility in re-entry to medical training when the PhD is complete. Medical training interfaces with 5 biomedical graduate programs in Cell, Molecular, & Developmental Biology, Genetics, Immunology, Molecular Microbiology, Neuroscience, and a graduate program in Clinical and Translational Science. Our integrated curriculum also includes a Clinical Implications of Basic Research course, an annual retreat, a career-oriented dinner program, and other skill-building workshops such as Resilience and Physician Leadership. These include preparation for the transition from graduate school to clinical medical training, mentoring for NIH applications, and a workshop focused on choosing research-focused residencies. With a strong institutional commitment to the MSTP, we have expanded our enrollment through a Second Portal program for trainees already enrolled in medical school and have a target size of five entering trainees each year. Our MSTP has graduated 109 trainees, and 38 are currently enrolled. We request funding for 10 positions in this application.

Public health relevance
Project Narrative Improving public health and fostering future leaders who can meet the unknown future challenges and unmet needs in health care requires the training of individuals who will incorporate contemporary medical knowledge and best practices, and also will explore the fundamental, scientific and evidential basis of medicine. Our program trains MD-PhD students to become the physician-scientist leaders who will expand the frontiers of medicine and science, thereby identifying new paradigms for the diagnosis, prevention and treatment of human disease. Through our program, students acquire the lifelong skills in medicine, science and personal resilience needed to understand the mechanisms underlying disease, resolve key healthcare issues and drive innovative biomedical research over the course of their careers, thereby improving the health and well-being of current and future generations.